microRNA tuning of neural crest osteogenesis

PROJECT SUMMARY Every 4 ½ minutes, a baby is born with a birth defect, including such that affect the craniofacial skeleton. These facial malformations cause disfigurement leading to long-term psychological impact and are often associated with physical dysfunction imposing tremendous burden on the affected individuals and their families. Although the causes for most of these severe developmental pathologies are still unknown, it is clear that the inappropriate formation and differentiation of neural crest (NC) cells, the cells that normally give rise to the osteoblasts in the affected craniofacial skeleton, plays a large part. Given the causality between miscontrolled osteoblast differentiation from the NC and the tissue malformations arising from it, an understanding of the molecular networks underlying NC development is crucial for the potential treatment or prevention of craniofacial defects, yet far from complete. For instance, the contribution of epigenetic regulators, such as microRNAs (miRNAs), to the formation of the craniofacial bones remains understudied, despite their potential as diagnostic markers. We study here the epigenetic regulation of NC development by a specific miRNA, miR361, which we have previously identified in our lab as being pro-osteogenic in an in vitro model of NC-osteogenesis. Characterizing the miR361 expression domain in mouse and Xenopus embryos coupled with the assessment of skeletal and NC phenotypes when miR361 is knocked out or overexpressed in these organisms will validate the function of miR361 during NC development in vivo. Assessing miR361's contribution to NC development using an innovative and effective in vitro NC differentiation model based on human pluripotent stem cells will show relevance for this microRNA in human development. Elaborating on the direct miR361 mRNA target and identifying NC-specific loci that are transcriptionally regulated downstream of miR361 will define the relationship between this miRNA, transcriptional activation in NC cells and their subsequent propensity for osteoblast differentiation. This knowledge is highly impactful as there is currently no information in the public domain that could explain the role of miR361 in bone development from the NC nor in any aspect of differentiation, development or disease. The results gained from this study will aid in the development of a more complete understanding of craniofacial osteogenesis that is inclusive of epigenetic regulators and promises to illuminate causes and treatments of developmental disorders of the craniofacial region in humans, which has a high priority in NIDCR's long-range plan.

Public health relevance
PROJECT NARRATIVE Defective neural crest differentiation contributes to the occurrence of craniofacial birth defects that place substantial psychological and physical burden on the affected individuals due to disfigurement and dysfunction. We propose here to elucidate the role of microRNA361 as an epigenetic regulator of craniofacial skeletogenesis and characterize its molecular mechanism of action. Understanding the molecular underpinnings of neural crest differentiation has the potential to provide novel targets for the early diagnosis of craniofacial birth defects.